Autoimmunity Centers of Excellence Discretionary Fund for Clinical Trials

The Autoimmunity Centers of Excellence Discretionary Fund supports Pilot Research Projects, Clinical Trials, and Mechanistic Research and Shared Research Agenda Projects for a variety of autoimmune diseases.